Methods to unveil sex-specific genetic architecture in trans-ancestry meta-analysis

ABSTRACT
Large scale genetic datasets have revolutionized human genetic research. In the past decade, genome-wide
association studies have identified numerous genetic variants associated with various complex traits. These
discoveries have informed new biology and led to novel therapeutics. Yet, most studies focused on European
samples and most of the studies were conducted by pooling both sexes together. Sex-specific genetic
architecture in diverse populations remains largely elusive. As the next step, consortia efforts have begun to
aggregate datasets from diverse non-European populations. Meta-analysis is often employed in large consortium
studies There is a compelling need to develop methods that can effectively conduct trans-ancestry meta-
analysis. To this end, we will develop a series of innovative methods to improve the power for association
mapping, the precision of fine mapping and the accuracy of polygenic predictions in trans -ancestry analysis.
Resulting methods will be applied to a series of heart, lung, and blood related traits, in collaboration with a
number of consortia studies. This is a continuation of our strong track record of method development in statistical
genetics. We will implement the methods into a few widely used tools, including RVTESTS, SEQMINER, and
RAREMETAL, which will not only benefit our own study but also other researchers in the field.

Public health relevance
PROJECT NARRATIVE Heart, lung and blood related diseases are leading causes of death in the US and around the world. Understanding the sex-specific genetic architecture for the risk factors for these traits in diverse populations (e.g. tobacco and alcohol use, lipids levels, obesity, etc) can aid in the discovery of the underlying biology, inform preventive strategies, and improve risk prediction, which are of great public health relevance.